RCT of an intersectional stigma intervention to sustain viral suppression among women living with serious mental illness and HIV in Botswana

Abstract.
Reducing stigma to ensure viral load (VL) suppression for women with serious mental illness (SMI) and HIV is a
global priority, including in Botswana, where the intersectional stigma of SMI, HIV and womanhood is
marginalizing in ways that impede adherence to both psychiatric medications and antiretroviral therapy (ART),
which can threaten VL suppression. We apply our novel ‘what matters most’ (WMM) approach to target
intersectional stigma faced by women with SMI and HIV in Botswana via a stigma-reduction intervention in the
high-risk transition period after discharge from an initial psychiatric hospitalization. WMM conceptualizes how
stigma is felt most acutely when people are unable to achieve ‘full personhood’ by participating in the activities
that ‘matter most’ in their local context. In prior research, we found the core value for ‘full womanhood’ in
Botswana is achieved by being the ‘foundation of the household’ and is threatened by perceived: 1)
incompetence in fulfilling the duties of a family caregiver associated with SMI and 2) promiscuity associated with
having HIV. In Botswana, family acceptance as a viable ‘family caregiver’ is also key to achieving ‘full status’ as
a woman. As such, the risks of being identified as having SMI and HIV (e.g., partner/family abandonment) can
deter psychiatric and ART treatment adherence. Promoting capabilities that ‘matter most’ for achieving ‘full
womanhood’ could enable longer-term stigma reduction after psychiatric discharge, when women are
reintegrating into their communities, and improve ART adherence and promote sustained VL suppression. Our
group-based WMM stigma intervention is co-led by a peer woman who has coped effectively with SMI and HIV
stigma. The WMM stigma intervention model was piloted among pregnant women with HIV in Botswana with
promising reductions in stigma and depressive symptoms up to 4-months postpartum. We now test whether a
WMM intervention tailored for women with SMI and HIV will reduce intersectional stigma and facilitate VL
suppression. We propose a two-arm randomized controlled trial (RCT; N=180) with a 4-month follow-up to
compare the effectiveness of 1) WMM-based intersectional stigma intervention delivered as clients transition
from psychiatric hospitalization to outpatient care (‘WMM Stigma Intervention;’ n=90); and 2) attention control
following a similar format to isolate the effects of the intervention (n=90). Because family are commonly involved
in the care of people with SMI and face severe stigma, we propose a parallel, group stigma intervention among
family members, as addressing familial stigma could facilitate treatment adherence. Finally, because
intersectional stigma is reinforced at systemic levels, we seek to empower women with SMI and HIV to influence
structural change by coleading policymaker workshops to reduce stigma among policymakers and spur
policymakers to address the unique needs of women with SMI and HIV via future policies.

Public health relevance
PROJECT NARRATIVE The study goal is to promote viral load suppression among women with serious mental illness (SMI) and HIV in Botswana, given that these women are especially vulnerable to psychiatric medication nonadherence and symptom exacerbation, which are made worse by stigma and threaten antiretroviral therapy (ART) adherence. We propose to test an intervention to reduce stigma due to the statuses of SMI and HIV, against an attention control condition, in the high-risk transition period after discharge from an initial psychiatric hospitalization. Enabling women with SMI and HIV to resist stigma has the potential to improve their HIV outcomes and empower these women to elicit broader, structural-level change.